Molecular Circuits in the Hematopoietic Stem Cell Niche

In mammals, hematopoietic stem cells (HSCs) first arise from a specialized hemogenic endothelium that lines
the developing embryonic aorta, migrate to and expand in the fetal liver, and ultimately colonize the bone
marrow, which supports hematopoiesis throughout adult life. These distinct anatomic locations harbor
specialized microenvironments that support the developmental maturation, expansion, and ultimately the
balance of self-renewal and differentiation of HSCs. The transcriptional programs that promote formation and
differentiation of hematopoietic stem and progenitor cells (HSPCs) have been widely interrogated, but much
remains to be learned about the supportive niche cells of the hematopoietic microenvironment and the
mechanisms of cell-cell interaction that specify HSC emergence during development, HSC migration, lodging,
and expansion in fetal niches, and the ultimate quiescence, self-renewal, and differentiation in the bone
marrow. In our preliminary data, we have gathered evidence for number of cell types, including endothelial
cells, mesenchymal cells, macrophages, neural crest derivatives, and somites as components of the
hematopoietic niche. We will gather comprehensive “omics” data to catalogue the gene expression programs
within the distinct hematopoietic niche cells that occur during development in the aorta-gonad-mesonephros
(AGM), fetal liver, bone marrow, and placenta (aim 1). Our approach begins with tomo-seq, which enables us
to discover gene expression patterns unique to cell populations like endothelium that have region-specific
specialization. We will validate cell-specific expression in FACS purified cells by single cell RNA-seq and in situ
hybridization, and will document functionality using morpholino and CRISPR knock-down in the experimentally
tractable zebrafish model. We then use ATAC-seq to define functional open chromatin around these genes,
and motif-finding software to identify DNA-binding regulatory factors that are candidate drivers of
hematopoietic cell fate. We will employ a computational pipeline and develop novel algorithms to analyze these
data (aim 2). Hypotheses emerging from aims 1 and 2 will be tested by constructing novel reporter strains of
zebrafish and mice, as well as engineered pluripotent stem cells carrying synthetic reporters and drivers (aim
3). Our goal is to define the molecular circuitry that specifies niche cells during the critical periods of HSC
emergence and expansion, and to probe cross-talk between niche elements and HSPCs. We hope to glean
unique insights into the molecular mechanisms that drive hematopoietic formation and maturation during
embryonic development, and to enhance our understanding of HSC maintenance, quiescence, self-renewal
and differentiation.

Public health relevance
Hematopoietic Stem Cells (HSCs) are the functional units of therapeutic bone marrow transplantation. A major goal of hematology research is in vitro expansion of HSCs from umbilical cord blood and other sources to boost stem cell numbers for transplantation, gene transfer and gene editing. Strategies for HSC expansion typically entail co-culture with supportive cell types to recapitulate the hematopoietic microenvironment, or niche, which regulates HSC maintenance, self-renewal, and differentiation. We propose to generate a most comprehensive single cell atlas of the ecosystem of embryonic hematopoiesis. Elucidating the molecular identity of niche cells, specifying their derivation both in vitro and in vivo through the recreation of synthetic niches, and understanding the cell-cell communication that underlies niche interactions with HSPCs is an important goal that has enormous promise to impact ex vivo culture, expansion, and genetic manipulation of HSCs for experimental and therapeutic applications.